31st Meeting of the American Society for Rickettsiology

Meeting Summary: 31st Meeting of the American Society for Rickettsiology
Rickettsial diseases are significant domestic and global causes of morbidity and death. In the United States, tick-
borne rickettsial infections are responsible a majority of hospital admissions, ICU admissions, and fatalities.
Many new Rickettsia and related species are recognized globally for their increase in prevalence and nearly all
are neglected. The absence of an approved vaccine for humans, combined with insufficient laboratory
diagnostics and challenging clinical diagnosis, suggest a public health need to examine the biology of rickettsiae.
It is now realized that these obligate intracellular bacteria can vary from highly pathogenic to, in some cases,
essential mutualistic organisms in arthropod vectors. Fundamental investigations into the differences in rickettsial
interactions between vertebrate hosts and arthropod vectors are needed to address critical knowledge gaps.
Research into the mechanisms that drive the biological interaction between Rickettsia and hosts in congruent
with the Tick-Borne Disease Working Group report to Congress. This report emphasizes that understanding the
factors contributing to Rickettsia’s ability to cause disease, would drive innovation and novel countermeasure
development. The American Society for Rickettsiology (ASR) has a long history of organizing meetings that
foster scientific interactions and intellectual exchange among experts on rickettsial diseases. The 31st Meeting
of the ASR will be held June 25-28, 2022 in Greenville, SC, a central venue that will facilitate scientists,
investigators and clinicians to gather, exchange ideas, and information, and to establish new multidisciplinary
collaborations. Approximately 200 attendees representing early stage investigators, established scientists, and
clinicians from academia, government, and industry are anticipated to attend. The conference’s overarching goal
is to advance knowledge and stimulate interactions through oral presentations and poster sessions with
audience-interactive and networking opportunities. To address the knowledge gaps, we propose a theme for the
meeting entitled, “Advances in the Biological and Molecular Mechanisms of Rickettsial Pathogenesis.” The
meeting’s aims are to (i) promote scientific exchange among participants through lectures and short talks; (ii)
encourage participation by early career investigators and those underrepresented in the biomedical sciences
through travel grants, research presentation opportunities, and by involvement in significant meeting organization
roles; (iii) present cutting-edge research of diseases caused by arthropod-borne/obligate intracellular pathogens;
and, (iv) foster intellectual exchange and networking between early career and established investigators.
Participants’ child care needs and disability access will also be addressed. Support for travel awards for early
career investigators and trainees from underrepresented groups, cost of coordination, and for audio-visual
services and program production is requested.

Public health relevance
Project Narrative Rickettsial diseases caused by arthropod vector-borne obligate intracellular bacteria have had grave impacts on human health throughout history, yet no approved vaccine against any human rickettsial disease exists, antibiotic choices for treating them are limited, and little is known about disease mechanisms that could facilitate improved alternative and adjunctive treatments, despite resurgences of the disease. To address fundamental knowledge gaps in the field of Rickettsiology, the meeting will assemble clinicians, researchers, public health scientists and administrators, and industry representatives whose interests center on the biology of these unique bacteria so as to better understand their interactions with arthropod vectors and with mammalian host cells in the process of causing disease. By the efforts of 24 committee members representing a mix of senior, mid-career and early-career scientists from diverse and underrepresented groups, the meeting will catalyze an intellectual exchange and drive collaborative multidisciplinary research to fill the knowledge gaps such that basic science discoveries are readily translated into laboratory tests, drugs and effective vaccines.